Optimizing diabetes technology use for Latinx youth through DREAM (Device use Reimagined through Education And Mentorship) virtual peer groups

PROJECT SUMMARY/ABSTRACT
Strict glycemic control is critical for optimal type 1 diabetes (T1D) outcomes but remains challenging for youth
from historically marginalized ethnic groups, in whom hemoglobin A1c (A1c) levels are consistently the highest
in the nation. In California, Latinx youth are the largest marginalized ethnic group with T1D, but they
experience less optimal glycemic control than their White counterparts. Continuous glucose monitoring, insulin
pumps, and automated insulin delivery systems can assist with achievement of target A1c levels, but Latinx
youth have lower rates of diabetes device use compared to White youth. Virtual peer groups (VPGs) can
improve patient engagement and diabetes self-care in Latinx youth, and preliminary data suggest that VPGs
may increase the use of diabetes technology in this population. Jenise Wong, MD PhD, and Jennifer
Raymond, MD MCR, propose this project grant with the objective to increase the adoption and sustained use
of diabetes devices in Latinx adolescents with T1D by engaging them and their families in the development
and evaluation of a VPG intervention designed to improve technology use. This project will engage multiple
stakeholders (patients, families, health care workers) from three clinic populations in California (Children’s
Hospital of Los Angeles, University of California Davis, and University of California San Francisco) and result in
the DREAM (Device use Reimagined through Education And Mentorship) program. In collaboration with a
multidisciplinary team of pediatric endocrinologists, psychologists, and public health experts, the researchers
propose a project with the following aims: (1) partner with stakeholders to adapt a virtual peer group model to
promote the initiation and continued use of diabetes technology among Latinx adolescents with T1D, (2)
evaluate the feasibility and acceptability of DREAM in a single arm, pragmatic trial, and (3) assess the effect of
DREAM on clinical and patient-centered outcomes. These aims will be addressed in a formative phase and a
clinical trial phase. In Phase 1, the research team will address Aim 1 by engaging stakeholders in focus groups
and semi-structured interviews to obtain qualitative data that will directly inform the design of the DREAM
VPGs and the clinical trial. A subset of stakeholders will form Advisory Councils who will provide longitudinal
input during the clinical trial. In Phase 2, the research team will conduct a single arm, pragmatic trial of the
DREAM intervention in 120 Latinx youth aged 13 to <18 years with T1D, recruited from three pediatric diabetes
clinic populations in California. To address Aim 2, the researchers will collect qualitative feedback from focus
groups and quantitative data on VPG feasibility, appropriateness, and acceptability as primary outcomes.
Preliminary data on clinical outcomes of A1c and hospital utilization, and patient-centered outcomes will be
assessed to address Aim 3. The results of this study will result in a novel, culturally appropriate, VPG model to
increase use of diabetes technology for Latinx youth with T1D that may be further adapted and disseminated
for other age groups, geographic settings, or racial/ethnic populations.

Public health relevance
PROJECT NARRATIVE Diabetes technology, such as insulin pumps and continuous glucose monitoring devices, can help improve glucose control for people with type 1 diabetes (T1D), which keeps them at lower risk for diabetes complications, but many Latinx adolescents, who make up the largest marginalized ethnic group of youth with T1D in California, use these devices less often and have less optimal glucose control compared to White youth. The goals of this project are to work directly with Latinx youth, their families, and diabetes care team members in California to develop DREAM, Device use Reimagined through Education And Mentorship, a virtual peer group (VPG) intervention that will encourage and support the use of diabetes devices in Latinx adolescents with T1D. With these stakeholders, the researchers will design and pilot test the feasibility of DREAM, and the results of the study will be used to improve the use of diabetes technology and clinical and patient-centered outcomes for Latinx youth with T1D.